Neurophysiology of locomotor adaptation and freezing of gait in Parkinson's Disease

PROJECT SUMMARY
Freezing of gait (FoG) is a common symptom in Parkinson’s disease (PD), characterized by a sudden reduction
in forward stepping movement, leading to falls and reduced quality of life. The combination of FoG and difficulties
in adapting walking patterns to different situations further increases the risk of falls in PD, highlighting a critical
need for improved understanding and strategies to alleviate these gait impairments. This project aims to
understand the neural mechanisms underlying locomotor adaptation deficits in PD with FoG. We will study neural
activity in the globus pallidus internus (GPi), the major basal ganglia output center, using novel deep brain
stimulation (DBS) technology with recording capabilities during treadmill walking in PD. We posit that abnormal
neural oscillations in the GPi disrupts the regulation of human walking, and we hypothesize that an increase in
13-30 Hz oscillatory activity may lead to locomotor adaptation deficits in PD with FoG. The proposed studies will
include 60 PD patients implanted with GPi-DBS, 20 of whom will have the Medtronic Percept PC capable of
recording local field potential (LFPs). Locomotor adaptation will be studied using a split-belt treadmill paradigm,
consisting of baseline (1:1 speed ratio), split-belt adaptation (2:1) and post-adaptation (1:1) walking. The
experiments will be performed under DBS ON and DBS OFF conditions. We will capture joint kinematics and
electromyography (EMG) to characterize locomotor adaptation deficits and various types of FoG manifestation.
GPi LFP recordings will be aligned with motion capture and EMG data. Aim 1 will identify GPi LFP oscillations
related to locomotor adaptation deficits and FoG in PD. Aim 2 will determine whether GPi-DBS facilitates split-
belt walking adaptation in PD. This work has theoretical and translational significance because the outcomes will
provide new scientific knowledge regarding the role of pallidal neural activity in human walking adaptation, and
identify new strategies to mitigate locomotor adaptation deficits associated with FoG in PD.

Public health relevance
NARRATIVE This project will use advanced deep brain stimulation (DBS) technology to explore the neurophysiology underlying locomotor adaptation deficits and freezing of gait in Parkinson’s disease. By identifying key markers and understanding how DBS can modify locomotor adaptation, the insights gained will lay a foundation for designing targeted therapies to improve gait and reduce falls in people with Parkinson’s disease.